Chlamydia-infected Epithelial Cell Secretion of Immunoregulatory Cytokines

[unreadable] DESCRIPTION (provided by applicant): NO ABSTRACT WAS PROVIDED BY THE PI. [unreadable] [unreadable] [unreadable] [unreadable]